Development and Pilot Testing of an Intervention to Support Interhospital Transfer Decisions (SITe) Regarding Older Adults with Emergency General Surgery Diagnoses

Project Summary
Every year, nearly 240,000 patients aged 65 and older are transferred between emergency departments (EDs)
and hospitals for non-traumatic surgical emergencies. These transfers include emergency general surgery
(EGS) diagnoses such as bowel obstructions, diverticulitis, and soft tissue infections. Transferred patients
experience worse outcomes than those directly admitted from EDs within a given hospital. A contributing factor
to the worse outcomes of transferred older EGS patients is that care coordination suffers during interhospital
transfers. Transfers fragment care and separate older patients from their regular healthcare providers,
surrogate decision makers, and social support systems. Comorbid conditions and acute illness can limit older
adults’ cognitive capacity to provide their health history and fully participate in medical decision-making. Due to
these threats, communication between referring and accepting providers is critical to decisions to transfer older
adults. Yet, the Principal Investigator’s data show that conversations about transfer decisions are incomplete
and inconsistent, resulting in poor care coordination, increased emotional labor among providers, a lack of
consensus between providers about the transfer decision, and potentially avoidable transfers.
Standardizing handoffs for interhospital transfers between inpatient units facilitates communication, resulting in
improved patient care and outcomes. Similarly, standardizing conversations about interhospital transfer
decisions has the potential to benefit older patients. To standardize communication about transfer decisions,
we will develop and pilot-test an intervention to Support Interhospital Transfer decisions (SITe) that is specific
to the needs of older EGS patients and utilizes extant transfer processes through the following aims. Aim 1:
Engage key stakeholders to develop the SITe intervention for older EGS patients by adapting an existing
intervention for interhospital handoffs. Aim 2: Assess the acceptability of the SITe intervention, test the
feasibility of study procedures, and explore efficacy outcomes for evaluation in a future, larger clinical trial.
My long-term goal is to improve outcomes for older EGS patients through innovative research on care
coordination and a career as an independently funded, surgeon-scientist and clinical leader at the intersection
of EGS and aging research. This proposal includes a comprehensive, tailored Professional Development Plan
that combines mentorship and educational activities with experiential research that will prepare me
scientifically and professionally to become a future leader in aging-focused research. My talented and
dedicated mentoring team consists of clinician-researchers who are leaders in aging-related research with
expertise in transitions of care, communication among medical providers, and intervention development. This
proposal will produce preliminary data to support an extramural, R-level clinical trial that will have a substantial
impact as we improve the communication between providers regarding decisions to transfer older patients.

Public health relevance
Project Narrative Every year, nearly 240,000 patients age 65 and older are transferred between acute care hospitals for non- traumatic surgical emergencies, and these patients experience worse outcomes than patients admitted directly from an emergency department within a given hospital. Care coordination for older patients with emergency general surgery (EGS) diagnoses suffers because conversations between referring and accepting providers regarding decisions to transfer are ineffective, incomplete, and inefficient. To standardize a method to support transfer decisions that is tailored to older adults within extant transfer processes, we will (1) engage key stakeholders to develop the intervention to Support Interhospital Transfer Decisions (SITe) for older EGS patients by adapting an existing intervention for interhospital handoffs and (2) assess the acceptability of the SITe intervention, test the feasibility of study procedures, and explore efficacy outcomes for evaluation in a future, larger clinical trial.